Studying 24-hour rhythms of light exposure, alignment with rest-activity cycle, and cardiometabolic health in a nationally representative sample

PROJECT SUMMARY
Circadian rhythms, generated by endogenous molecular clocks and entrained by the light-dark cycle, play a
central role in orchestrating many physiological and behavioral processes related to cardiometabolic health. A
growing body of evidence has linked light exposure at different times of the day and cardiometabolic outcomes,
suggesting that characteristics of 24-hour light-dark cycle may be unique predictors of disease risk. However,
there is a lack of investigation focusing on comprehensively assessing 24-hour light exposure, and in particular,
its alignment with diurnal behavioral, to understand its health implications in human populations. A well-
established hallmark of a healthy circadian timing system is the synchronization and proper alignment of multiple
elements, such as between the environmental stimuli (e.g., light-dark cycle) and diurnal behaviors (e.g., activity-
rest cycle). Our pilot study in older men applied phasor analysis to assess the alighnment between actigraphy-
measured 24-hour light-dark and activity-rest cycles, and we found that impaired alignment between the two was
associated with diabetes. These findings suggest that poor synchronization between the timing of light exposure
and activity patterns may be a unique predictor of cardiometabolic risk, a novel hypothesis that needs to be
tested in broader populations. We propose to test this hypothesis by conducting secondary data analysis in the
National Health and Nutrition Examination Survey (NHANES, 2011-2014), which has detailed data on 24-hour
light and activity patterns and rich information on cardiometabolic health. Moreover, the diverse and nationally
representative sample will allow us to determine how 24-hour patterns of light exposure, its interrelationship with
activity-rest cycles, and their associations with cardiometabolic outcomes may vary among subgroups with
different demographic, socioeconomic, and occupational characteristics. Aim 1 Study characteristics of 24-
hour light exposure and its alignment with rest and activity patterns in relation to cardiometabolic health
in adult participants in NHANES. In this aim we will apply parametric and nonparametric methods to
characterize multiple aspects of light-dark cycles and phasor analysis to characterize the alignment between
light-dark and activity-rest cycles to study their associations with cardiometabolic outcomes. Aim 2 Study light
exposure, alignment with rest and activity, and their associations with cardiometabolic health in adult
populations with different demographic, socioeconomic and occupational attributes. In this aim we will
examine multiple population attributes as determinants of 24-hour light-dark cycles and its alignment with activity-
rest cycles, and as moderators of the association between light exposure and cardiometabolic health. Light
exposure is a potentially modifiable risk factor for cardiometabolic diseases, and our study will help better
understand the contribution of light exposure to cardiometabolic health and disease disparities, and provide
evidence for developing preventive and therapeutic interventions aimed at manipulating light exposure and
activity-rest patterns to improve circadian function and cardiometabolic health.

Public health relevance
PROJECT NARRATIVE The proposed study has potentially important public health and clinical impacts because it will lead to better understanding about the role of light exposure patterns and its interrelationship with activity and rest behaviors in cardiometabolic health. Moreover, our study will also lead to a deeper understanding about population differences in 24-hour light exposure and its alignment with activity patterns in the US, which may provide insight into contributing factors to population disparities in cardiometabolic health. Finally, our study findings may motivate and inform the development of interventions aim at improving circadian function, such as timed light exposure, carefully designed exercise schedules, and better sleep hygiene, to improve cardiometabolic health.